ASSESSMENT OF HIV INFECTION IN SPANISH SERONEGATIVE IVDA'S AND THEIR PARTNERS

Intravenous drug abusers (IVDAs) are a major target for the spread of HIV in Spain. A prevalence rate of 8-15% of HIV antibodies among partners of IVDAs , although higher rates have been suggested since a substantial proportion of these people may be latently infected. Intravenous drug abusers (IVDAs) are a major target for the spread of HIV in Spain. A prevalence rate of 8-15% of HIV antibodies among partners of IVDAs, although higher rates have been suggested since a substantial proportion of these people may be latently infected. The presence of latent HIV infection was investigated by PCR. Genomic DNA was prepared from (PBMCs) of 32 seronegative partners of seropositive IVDAs and 5 partners of seropositive promiscuous subjects. Primers were derived from the gag (SK38/39) and env (68/69) regions. All samples were also tested for HIV antigenaemia. 11/32 heterosexual partners of IVDAs and 5 partners of seropositive promiscuous subjects. 11 of 32 heterosexual partners of IVDAs were positive for gag sequences by PCR. 3 were positive for env sequences. All 5 heterosexual partners of the promiscuous infected subjects were positive, but 4 also had HIV antibodies. The 13 subjects who were positive by PCR but did not have antibodies to HIV were negative for HIV antigen. Our study suggests that there may be a high proportion of silent HIV infection in Spanish IVDAs. We are at present evaluating the prevalence in a larger population of IVDAs and homosexual men and their partners who remain seronegative. In a separate study, HIV-2 infection is being surveyed in a small group of prostitutes from Southern Spain (Seville) using primers from the LTR region of HIV-2 (SK 89/90). HIV-2 transmission among high risk individuals is also being assessed using HIV-2 specific primers developed in our laboratory (HX1/HX2). The HIV status of a 42 year old homosexual male, who was seronegative, but had symptoms of Kaposi's Sarcoma was determined by PCR. This individual was PCR-ve and AB-ve. RNA- PCR on PBLs using tat primers also yielded negative results, suggesting that this may be a case of KS in the absence of HIV infection. This finding opens up the possibility of the involvement of another etiologic agent in KS. Other similar cases are being studied to further evaluate this finding.